Michigan Center for Diabetes Translational Research

– OVERALL
The Michigan Center for Diabetes Translational Research (MCDTR) supports 110 current members, regional, national, and international collaborators, and aims to engage and support new members in multiple disciplines to conduct T2-T4 diabetes research with specific emphasis on novel approaches to measure and improve health outcomes.
Over past years, the MCDTR has expanded its research base focused on community and health system interventions that span T2-T4 translation. There is a great need now to support new research evaluating novel approaches to improve health outcomes in diabetes prevention and management and to incorporate rigorous measurement of and innovative strategies to improve health outcomes within all our members' research. We aim to promote research that supports the development, implementation, evaluation, and dissemination of effective interventions, programs, and policies that improve health outcomes.
The MCDTR will:1) Raise awareness of and interest in T2-T4 translational research in diabetes and create an environment that supports important and innovative research; 2) Foster and help sustain multidisciplinary, novel, and cross-sectoral collaborations, including with multiple health and social service organizations where appropriate to advance emerging scientific areas of translational and health outcomes research; 3) Provide core services to support members’ research programs using best practices in translational and health outcomes research; 4) Through enrichment, pilot and feasibility grant, and other programs, attract, develop, and support early and other researchers to conduct research that improves diabetes prevention, treatment, and population health.
The Center supports four cores. The Administration Core maintains the Research Base and is responsible for the MCDTR's direction, functioning, finances, and web site. It administers the Pilot and Feasibility Study Grants Program, the Enrichment Program, and the Cross-Sectoral Collaborations initiative that fosters and sustains partnerships between MCDTR investigators and multiple sectoral partners that span local and state health departments, federally qualified health centers, and community organizations. The Evaluation Methods and Intervention Strategies Core focuses on cutting-edge design and analysis methods and technology-based approaches to intervention delivery, cross-sectoral communication, and outreach to improve access of and ongoing support to populations facing health differences. The Addressing Social and Behavioral Determinants of Health Core provides expertise on state-of-the art approaches to identify, measure, and meet unmet needs and design interventions and policies that effectively address both social and behavioral determinants of improved diabetes and population health outcomes. The Leveraging Community, Family, and Peer Support Core helps investigators design and evaluate novel intervention approaches that effectively mobilize and evaluate different types and combinations of community, family, and peer support to both address social needs and support healthy behaviors to improve diabetes prevention, and management.

Public health relevance
Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences to describe the relevance of this research to public health. The Michigan Center for Diabetes Translational Research (MCDTR) has a strong track record of strengthening its members' capacities to design and test in real-life settings innovative evidence-based approaches to prevent and manage diabetes. We will build on this work by mobilizing multidisciplinary expertise and resources on the most effective, innovative, and scalable strategies to develop and evaluate interventions and policies involving multiple sectors to address unmet needs, provide ongoing support for healthy behaviors, and improve cross-sectoral care and service delivery to improve health outcomes among people with risk factors for and with diabetes. The MCDTR will reach out to and engage investigators and practitioners in relevant fields, with a particular emphasis on junior investigators. We will provide multidisciplinary individual and group consultations, training, and workshops; provide Pilot and Feasibility funding and mentorship; and conduct enrichment activities to catalyze and sustain effective cross-disciplinary and cross-sectoral collaborations to improve health outcomes. Modified Project Summary/Abstract Section – ADMINISTRATIVE CORE Enter the text here that is the new abstract information for your application. The Administration Core of the Michigan Center for Diabetes Translational Research (MCDTR) provides leadership, infrastructure, and resources to: 1) Raise awareness of, and interest in, research along the spectrum of diabetes T2-T4 translational research with a particular emphasis on novel approaches to improve health outcomes and create an environment that supports such research; 2) Support new and established investigators in developing, implementing, and evaluating evidence-based approaches to improving diabetes care and outcomes among communities, health care organizations, and individuals. 3) Administer Cores that provide MCDTR members with services critical to T2-T4 translational research in diabetes, including addressing social and behavioral determinants of health, leveraging multiple strategies of providing self-management support, and rigorously designing, implementing, and evaluating evidence-based interventions and strategies. 4) Provide enrichment programming that fosters interdisciplinary and cross-sectoral collaborations to develop and support early stage and other researchers through education and training. 5) Administer a Pilot and Feasibility Study Grants Program to attract new researchers to diabetes translational research that improves health outcomes and enable awardees to generate sufficient bodies of preliminary data to successfully apply for research funding from NIH and other national granting agencies. (Administration Core) 6) Administer a cross-sectoral collaborations initiative that engages and pairs local and state partners with researchers aiming to improve fair access, care delivery, and health outcomes for people with and with risk for diabetes. 7) Maintain the Center’s website. The Administration Core is responsible for identifying and supporting researchers engaged in T2-T4 Diabetes translational research; for developing and implementing Cores to provide services to funded diabetes translational researchers locally, regionally, and nationally; for overseeing the allocation of Center resources; for providing an Enrichment Program; for implementing a process for solicitation, review, selection, monitoring, and follow-up of the Center’s Pilot and Feasibility Study Grants; for administering a cross sectoral collaborations initiative, and for developing and maintaining a website that integrates seamlessly with the Caswell Diabetes Institute and the NIDDK Diabetes Centers websites. Modified Specific Aims Section Enter the text here that is the new specific aims information for your application. The Michigan Center for Diabetes Translational Research (MCDTR) builds on the 40+ years of experience of the Michigan Diabetes Research and Training Center and 9 years of MCDTR successes. The goal of the Administration Core is to provide the oversight and infrastructure for the MCDTR to advance research along the spectrum of diabetes T2-T4 translational research to prevent diabetes and enhance health and well-being of people with diabetes. This goal will be accomplished through four main infrastructural mechanisms: 1) Organizational infrastructure, 2) Pre-determined selection processes of MCDTR membership that focus on promoting broad scientific representation in the MCDTR and in diabetes translational research; 3) The fostering of collaborations and scientific opportunities that promote research that supports rapid dissemination, implementation, and sustained use of effective interventions, programs, and policies; 4) Design and facilitation of professional development activities. The three translational cores (Core 1: Evaluation Methods and Intervention Strategies; Core 2: Social and Behavioral Determinants of Health; Core 3: Community, Family and Peer Support Core) of the MCDTR, along with an Enrichment Program, a Pilot and Feasibility Study (P/FS) Grants Program, and a Cross-Sectoral Collaborations initiative work together, under the oversight and coordination of the Administration Core. This infrastructure provides specialized expertise, resources, and best practices to raise awareness of and interest in rigorous diabetes translational research in health system and community settings. These elements catalyze the MCDTR to continually attract, develop, and retain new diabetes translational scholars who are committed to understanding and improving diabetes prevention and treatment through multi-modal, transdisciplinary research methods. The Administration Core of the MCDTR provides leadership, infrastructure, and resources to carry out the following specific aims: 1) Raise awareness of, and interest in, research along the spectrum of diabetes T2-T4 translational research with a particular emphasis on novel approaches to improve health outcomes and create an environment that supports such research; 2) Support new and established investigators in developing, implementing, and evaluating evidence-based approaches to improving diabetes care and outcomes among communities, health care organizations, and individuals. 3) Administer Cores that provide MCDTR members with services critical to T2-T4 translational research in diabetes, including addressing social and behavioral determinants of health, leveraging multiple strategies of providing self-management support, and rigorously designing, implementing, and evaluating evidence-based interventions and strategies. 4) Provide enrichment programming that fosters interdisciplinary and cross-sectoral collaborations to develop and support early stage and other researchers through education and training. 5) Administer a Pilot and Feasibility Study Grants Program to attract new researchers to diabetes translational research that improves health outcomes and enable awardees to generate sufficient bodies of preliminary data to successfully apply for research funding from NIH and other national granting agencies. (Administration Core) 6) Administer a cross-sectoral collaborations initiative that engages and pairs local and state partners with researchers aiming to improve fair access, care delivery, and health outcomes for people with and with risk for diabetes. 7) Maintain the Center’s website. Modified Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences to describe the relevance of this research to public health. NA Modified Project Summary/Abstract Section – CORE 1 - Evaluation Methods & Intervention Strategies Core Enter the text here that is the new abstract information for your application. The Evaluation Methods and Intervention Strategies Core (EMIS) Core’s mission is to assist investigators in the study design, protocol development, data acquisition/collection, statistical analysis, implementation and dissemination to examine questions related to the causes, prevention, and effective management of diabetes, its complications, and comorbidities. The EMIS Core supports investigators through consultation and collaboration, leads work-in progress sessions, develops and maintains centralized resources, and conducts workshops. In order to create economies of scale and leverage other resources, the EMIS Core’s activities are coordinated with other UM Centers and Institutes to provide a comprehensive, multidisciplinary approach to support translational research. The Specific Aims of Evaluation Methods & Intervention Strategies Core are: The Specific Aims of the Evaluation Methods & Intervention Strategies Core are: 1. To consult with investigators regarding study design, protocol development, data acquisition/collection, statistical analysis, implementation and dissemination of behavioral, clinical, and health systems-related translational research studies focused on the causes, prevention and management of diabetes, its complications, and comorbidities. 2. To conduct advanced biostatistical analyses, simulations, cost analyses, and data management in collaboration with funded investigators. 3. To facilitate the use of the Michigan Model of Diabetes Progression (MMDP) to evaluate the cost and health utilities of interventions and to rigorously assess cost-effectiveness. 4. To provide support for studies seeking to improve accessibility and effectiveness of care support using mobile, telephone, or web-based tools. 5. To support communication, collaboration and central resources for investigators working on translational research. The Core includes personnel with skills in using mobile, telephone, or web-based tools and in epidemiological methods; survey methodology; psychometric measurement; quasi-experimental designs; quality measurement and practice profiling; Managing, merging, and analyzing large administrative and clinical databases; and advanced biostatistical analysis and economic modeling. Modified Specific Aims Section Enter the text here that is the new specific aims information for your application. The Evaluation Methods and Intervention Strategies (EMIS) Core represents a merging of our previous Measurement & Methods Core and our Intervention & Technology Core. Both of these cores were highly successful and in great demand, as can be seen by their heavy use and the outstanding research produced in partnership between core faculty and investigators. As the MCDTR sharpens its focus on strengthening the capacity of MCDTR members to conduct research that improves health outcomes by combining these cores we aim to strengthen synergies between the evaluation methods and intervention strategies that members employ in their diabetes translational research to strengthen their research's rigor, innovativeness, and impact. These methods and strategies will take on many forms ranging from traditional study design and statistical evaluation to advanced methods focused on quasi-experimental design, implementation and dissemination science, adaptive trials, simulation science, and health informatics. This merging allows for greater parsimony of resources to enable the MCDTR to expand activities to inform interventions to improve health outcomes such as addressing both Social and Behavioral Determinants of Health (Core 2) and leveraging Community, Family, and Peer Support (Core 3). The EMIS Core is committed to continuing our mission of helping investigators locally and nationally to conduct research examining important questions related to the causes, prevention, and management of diabetes, its complications, comorbidities, and related conditions, such as obesity and metabolic disorders. Much of this past work has indeed been directed at research aiming to improve health outcomes through adapting to needs and preferences for tailored interventions that leverage e-health and telephone-based technologies to enhance outreach and between-clinic visit support, thereby reducing challenges to care for populations experiencing health differences. We look forward to building on prior work to help MCDTR members both incorporate state-of-the-art intervention strategies into their proposed translational research and utilize cutting-edge evaluation methods to assess these strategies. Our core experts will continue to encourage members to innovate in adopting better, more innovative methods for such research, especially with regard to quasi-experimental approaches, complex intervention designs, implementation and dissemination science, mobile health, economic and disease modeling, and measuring health-related quality-of-life and other patient-centered outcomes. The EMIS Core’s main mission is to assist investigators to design studies, both pilot & feasibility projects and major proposals, and to collect and analyze data to examine questions related to the causes, prevention, and control of diabetes, its complications, comorbidities, and those of related conditions. The EMIS Core supports investigators through consultation and collaboration, leads bi-weekly work-in-progress and monthly methods sessions, develops and maintains centralized resources, and coordinates workshops. The Core supports the full spectrum of translational research, including behavioral, clinical, health system, and community interventions. The Core includes experienced staff with skills in: 1) epidemiological methods, including experimental, quasi-experimental and observational study designs; 2) survey methodology; 3) psychometric analysis and measurement, including construction of scales to measure beliefs, attitudes, behaviors, self-management, functional condition, and patient-reported outcomes, including health-related quality of life,; 4) quality measurement and performance profiling; 5) technical aspects of managing, merging, and analyzing large administrative and clinical databases; 6) advanced biostatistical analysis and economic modeling; 7) implementation science; and 8) development and use of mobile devices, web-based tools, and telephone-based automated response interactive platforms. The EMIS core has five Specific Aims: 1. To consult with investigators regarding study design, protocol development, data acquisition/collection, statistical analysis, implementation and dissemination of behavioral, clinical, and health systems-related translational research studies focused on the causes, prevention and management of diabetes, its complications, and comorbidities. 2. To conduct advanced biostatistical analyses, simulations, cost analyses, and data management in collaboration with funded investigators. 3. To facilitate the use of the Michigan Model of Diabetes Progression (MMDP) to evaluate the cost and health utilities of interventions and to rigorously assess cost-effectiveness. 4. To provide support for studies seeking to improve accessibility and effectiveness of care support using mobile, telephone, or web-based tools. 5. To support communication, collaboration and central resources for investigators working on translational research. The Core includes personnel with skills in using mobile, telephone, or web-based tools and in epidemiological methods; survey methodology; psychometric measurement; quasi-experimental designs; quality measurement and practice profiling; Managing, merging, and analyzing large administrative and clinical databases; and advanced biostatistical analysis and economic modeling. Modified Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences to describe the relevance of this research to public health. NA Modified Project Summary/Abstract Section – CORE 2 - Addressing Social and Behavioral Determinants of Health Core Enter the text here that is the new abstract information for your application. Social determinants of health (SDOHs), defined as the conditions in the environments in which people are born, live, learn, work, play, worship, and age, are major drivers of diabetes-related morbidity, mortality, and differences in how care is received. Health behaviors such as care-seeking decisions, medication adherence, self-management, diet, and physical activity are also key factors that influence diabetes-related outcomes. In addition, these behavioral factors can be important mediators of the deleterious effects of SDOHs on diabetes-related outcomes, limiting the real-world impact of medical and public health advances in diabetes prevention and treatment and further contributing to disproportionate differences in population health. Despite growing recognition of the importance of socio-ecological, economic, and behavioral influences on the prevention and treatment of diabetes, much remains unknown about the most effective ways to address these influences to improve outcomes. Closing this gap in knowledge will require cross-disciplinary expertise in a broad range of social and behavioral determinants of health, experience with and access to strong cross-sector partnerships, and dissemination of novel research to key stakeholders who can implement, sustain, and disseminate findings.. The Addressing Social and Behavioral Determinants of Health Core seeks to catalyze state-of-the-art approaches to address socioecological, economic, and behavioral determinants of health in order to improve diabetes prevention, treatment, and outcomes. The Core will support Center investigators and trainees with measuring and intervening on social and behavioral determinants of health among various patient populations in a range of community and health care settings. This Core will have a particular focus on developing novel interventions that screen for and modify SDOHs, leverage insights from behavioral economics and other behavioral science frameworks, and support behavior change among various patient populations. This Core has four Specific Aims: Aim 1. Support state-of-the-art translational research to address socio-ecological, economic, and behavioral determinants of health in order to improve diabetes prevention, treatment, and outcomes. Aim 2. Integrate rigorous measurement of socio-ecological, economic, and behavioral determinants of health into translational diabetes research. Aim 3. Catalyze new collaborations to address socio-ecological, economic, and behavioral determinants of health in translational diabetes research. Aim 4. Develop early career investigators who will measure and target socio-ecological, economic, and behavioral determinants of health in translational diabetes research. Modified Specific Aims Section Enter the text here that is the new specific aims information for your application. The Addressing Social and Behavioral Determinants of Health Core will catalyze state-of-the-art approaches to address socio-ecological, economic, and behavioral determinants of health in order to eliminate measurable differenes in diabetes prevention and treatment. The Core will support Center investigators and trainees with measuring and intervening on social and behavioral determinants of health among various patient populations in a range of community and health care settings. This Core will have a particular focus on developing novel interventions that screen for and modify social determinants of health, leverage cutting-edge insights from behavioral economics and other behavioral science frameworks, support competent behavior change among various patient populations, and address the health consequences of individual, interpersonal, and structural determinants of health. This Core will achieve the following Specific Aims: Aim 1. Support state-of-the-art translational research to address socio-ecological, economic, and behavioral determinants of health in order to improve diabetes prevention, treatment, and outcomes. Aim 2. Integrate rigorous measurement of socio-ecological, economic, and behavioral determinants of health into translational diabetes research. Aim 3. Catalyze new collaborations to address socio-ecological, economic, and behavioral determinants of health in translational diabetes research. Aim 4. Develop early career investigators who will measure and target socio-ecological, economic, and behavioral determinants of health in translational diabetes research. The principle innovation of the Addressing Social and Behavioral Determinants of Health Core is the multidisciplinary focus and expertise to support the next generation of diabetes translational intervention efforts. Adverse psychosocial and economic circumstances each have profound effects on diabetes prevention and treatment. Further, social and behavioral determinants of health contribute to over 50% of differences in treatment and poor health outcomes. Historically, diabetes translational research has primarily focused on changing individual behavior and health outcomes, and relatively few interventions have directly targeted social determinants of health. In order to improve health outcomes for all people, the next generation of diabetes translational intervention research must take a multi-pronged approach to; 1) address both individual diabetes-related treatment and management needs; and 2) target the systems that influence social and behavioral determinants of health to improve their impact on diabetes-related outcomes. The multidisciplinary breadth and depth of expertise in the social and behavioral determinants of health among the faculty in this Core will catalyze a new pipeline of innovative diabetes translational research to ameliorate the conditions that result in diabetes and promote foundational change. Modified Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences to describe the relevance of this research to public health. NA Modified Project Summary/Abstract Section – CORE 3 - Leveraging Community, Peer, and Family Support Core (initial title) - Community, Family and Peer Support Core (current title) Enter the text here that is the new abstract information for your application. This Core facilitates research on and the development and evaluation of interventions leveraging community, peer, and family support to improve diabetes-related outcomes. We define community as the overarching ecosystem through which family and peer support is leveraged. Families and peers are defined broadly to include biological kin and individuals who comprise current and potential new social networks. These may consist of colleagues, neighbors, fellow church members, participants in a group medical visit, members of a virtual community, and even well-designed apps. Thus, this Core emphasizes a) the exchanges within and between communities, families, and peers (i.e., overlap); b) the characteristics and processes they share (i.e., interact); and c) the reciprocal association between their influence and their contexts – lifestyle, disease characteristics, stage of life, etc. (i.e., function). The Core supports studies into these topics, including interventions anchored in communities and health care systems that utilize community, peer, or family influences, broadly defined. To improve the design, implementation, and evaluation of interventions, this Core also supports studies exploring community, peer, and family support paths and how different contexts shape them. This Core’s objectives are centered on how support from communities, peers, and families impact and can best be mobilized to promote substantive positive changes in the lives and health of those affected by diabetes. The Core is an outgrowth of the Michigan-UNC Peer Support Core, funded through the Michigan Center for Diabetes Translational Research, 2016-24. It continues the Peer Support Core’s emphasis on the variety of peers and peer support approaches and the processes that undergird them, while expanding on these to include families and communities. With its national focus, the Core will serve colleagues at the University of Michigan, the University of North Carolina-Chapel Hill, and diabetes researchers across the US. This will include individual consultation to researchers and on research projects, national outreach, and facilitation such as through webinars and annual research workshops of a national Special Interest Group of researchers interested in the contributions of and interactions among community, peer, and family supports for improving diabetes prevention and management. Modified Specific Aims Section Enter the text here that is the new specific aims information for your application. This Core facilitates research on and the development and evaluation of interventions addressing community, peer, and family support. We define community as the overarching ecosystem through which family and peer support is leveraged. Families and peers are defined broadly to include biological kin and individuals who comprise current and potential new social networks. These may consist of colleagues, neighbors, participants in a group medical visit, members of a virtual community, and even well-designed apps. Thus, this Core emphasizes a) the exchanges within and between communities, families, and peers (i.e., overlap); b) the characteristics and processes they share (i.e., interact); and c) the reciprocal association between their influence and their contexts – lifestyle, disease characteristics, stage of life, etc. (i.e., function). The Core will support studies into these topics, including interventions anchored in communities and health care systems that utilize community, peer, or family influences, broadly defined. To improve the design, implementation, and evaluation of interventions, this Core will also support studies exploring community, peer, and family support paths and how different contexts shape them. This Core’s objectives are centered on how supports from communities, peers, and families impact and can best be mobilized to promote substantive positive changes in the lives and health of those affected by diabetes. The Core is an outgrowth of the Michigan-UNC Peer Support Core, funded through the Michigan Center for Diabetes Translational Research, 2016-21. It continues the Peer Support Core’s emphasis on the variety of peers and peer support approaches and the processes that undergird them, while expanding on these to include families and communities. With its national focus, the Core will serve colleagues at the University of Michigan, the University of North Carolina (UNC)-Chapel Hill, and diabetes researchers across the United States. This will include individual consultation to researchers and on research projects, national outreach, and facilitation such as through webinars and annual research workshops of a national Special Interest Group of researchers interested in the contributions of and interactions among community, peer, and family supports in diabetes prevention and management. Specific Aim 1. Provide consultation and assistance to researchers to increase and enhance T2-T4 translational research at the University of Michigan, UNC-Chapel Hill, and nationwide that addresses community, peer, and family supports and influences that affect, improve, or reduce measurable differences in prevention and management of diabetes. Specific Aim 2. Curate and disseminate resources nationwide for training those implementing programs as well as evaluation instruments and models and utilize social networking to promote and facilitate T2-T4 translational research and application of research addressing community, peer, and family influences in prevention, management, and reducing measurable differences in diabetes. Social networking will include Tuesday Tips, a weekly email of a research abstract or other document that goes to over 1,000 individuals in the US, and a total of 1,500 worldwide. Tuesday Tips, currently focusing on peer support from Community Health Workers, fellow patients, and other peers, will be expanded to encompass community and family as well as peer support and influences. Specific Aim 3. Develop a Special Interest Group to enhance quality of T2-T4 research and communication among leading and early career researchers addressing community, peer, and family influences in prevention and management of diabetes. The Special Interest Group will include researchers from the Centers for Diabetes Translational Research (CDTRs) and other major diabetes research settings. Activities will include webinars for presentation of research proposals, works in progress, and results and discussion of ways to link community, peer, and family approaches. A yearly research working conference will continue those of the previous project period in addressing key issues for community, peer, and family supports, such as addressing behavioral health and diabetes, and linking community, peer, and family supports with health care systems and within cross-sectoral partnerships. Modified Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences to describe the relevance of this research to public health. NA Modified Project Summary/Abstract Section – PILOT AND FEASIBILITY Enter the text here that is the new abstract information for your application. The Michigan Center for Diabetes Translational Research (MCDTR) Pilot/Feasibility (P/F) Grants Program provides critical startup support and mentorship for early-stage MCDTR investigators with high-quality T2 to T4 translational research proposals related to MCDTR research themes. A crucial feature of our successful P/F program has been its ability to stimulate interest in translational research in diabetes across many units of the university including the Medical School, School of Public Health, School of Nursing, School of Social Work, Institute for Social Research, Michigan Institute for Clinical and Health Research, Nutrition and Obesity Research Center, and the Center for Behavioral Solutions to Healthcare Engagement and Access. In addition, our support of multiple types of research casts a wide net, capturing the innovation of multidisciplinary research and facilitating the convergence of multiple research pathways focused ultimately on establishing and maintaining independence for early-stage investigators pursuing academic careers in diabetes translational research. We will continue to advance the P/F diabetes translational research agenda by further promoting research on social and behavioral determinants of health, population health, clinical and translational diabetes research and by establishing new collaborations across departments and divisions within the Medical School and across the campus. Modified Specific Aims Section Enter the text here that is the new specific aims information for your application. The Michigan Center for Diabetes Translational Research (MCDTR) Pilot/Feasibility (P/F) Grants Program provides critical start-up support and mentorship for high-quality T2 to T4 translational research proposals related to MCDTR research themes. A crucial feature of our successful P/F program has been its ability to stimulate interest in translational research in diabetes through many units of the university, including the Medical School, School of Public Health, School of Nursing, School of Social Work, Institute for Social Research, Michigan Institute for Clinical and Health Research, Nutrition and Obesity Research Center, and the Center for Behavioral Sol...